Validating Mouse Models of Prostatic Hyperplasia

OVERALL: SUMMARY
This P20 FORWARD Center will support a Project conceived and executed by three Early Stage Investigators
(ESIs) to address a problem that is important to the field of benign prostate research and to other fields more
broadly: the relevance of specific genetically engineered mouse models to human disease. The need for animal
models in biomedical research and the utility of mice, specifically, is well recognized and accepted. A number of
mouse models that purport to represent this disease have been generated. It is well recognized in the field that
none of these is a good overall representation of the human condition. As such, criticism of models is a common
issue in grant and paper review. This is a problem for all investigators in the field and can be particularly
damaging to ESIs who do not have resources to generate data from multiple lines. The Center will bring together
two biologists (Drs. Popovics and Vickman) with complementart skill sets and an interest in BPH, , contributing
expertise in mouse models and inflammation, with a bioinformatician (Dr. Lanman) to develop new approaches
to correlate transcriptomic data from mice with existing human BPH datasets to establish a reference dtabase
encompassing similarities and differences between individual mouse models and salient aspects of human
diseases. Successful development of these methods will allow broad application of the approach across a range
of diseases where such problems exist. The project will establish standards and benchmarks for comparing
mouse models to human BPH and identifying commonalities and disparities between the two. This will facilitate
the selection of the best models and will encourage similar characterization and comparison of other models in
the field. The data will be made available to the scientific community, as a collection in the CellxGene portal and
as an RShiny application. Consistent with the stated goals of the RFA the Administrative Core and its Director
(the PI, Dr. Hayward) will support the Project and specifically will provide access to resources and expertise to
assist the three ESIs in the development of new funding proposals derivative from the data generated here. The
Administrative Core will also oversee the fiscal and regulatory aspects of the Center and will provide mechanisms
for regular contacts between the Project investigators and the broader research community, in particular with
past and present CAIRIBU members, fostering opportunities to present data and furthering career opportunities.
The Adminstrative Core will also coordinate with experts in the field to support the development and submission
of new grant proposals from the ESIs. The immediate goal of this Center is to support the development of data
that will contribute to the career development and funding success of three early stage investigators in the field
of benign urologic research, bring new ideas and retain expertise in the field. The long-term goal is for the ESIs
to achieve significant independent careers.

Public health relevance
OVERALL: NARRATIVE Benign prostatic hyperplasi is one of the most common symptomatic conditions in aging men, resulting in millions of medical consultations, high healthcare expenditure and loss of productivity. This Center assembles a team of three Early Stage Investigators with expertise in benign urology, inflammation and bioinformatics to pursue a Project to identify the similarities and differences between mouse models of BPH and the human disease, establishing the most appropriate platforms on which to develop and test new medical strategies. The progress of the research, the career development of the team, grant applications derived from the project and data dissemination to the broader research community will be supported by the Administrative Core.